American Urological Association 2024 Early Career Investigator Workshop

2024 American Urological Association (AUA) Early-Career Investigators Workshop (ECIW)
Project Summary/Abstract
The 2024 AUA ECIW will be held November 8-9, 2024, at the AUA Headquarters in Linthicum, Maryland. The
workshop will provide intense, individualized instruction for a group of approximately thirty early-career
investigators and late-stage trainees on how to prepare innovative and competitive research grant applications,
primarily to the NIH with emphasis on grants in benign urology. Researchers, both faculty mentors and
attendees, will be MDs and PhDs from diverse perspectives and backgrounds. The program provides dual-
track instruction (early and advanced) by NIH-funded senior scientists. This workshop serves as a catalyst to
increase the quality of urologic research grant proposals submitted to the NIH.
The Principal Investigator (PI), Christine Riordan, PhD, LCSW-C, is AUA Director of Research. The Steering
Committee consists of a wide array of leaders in urologic research and research training. All faculty possess
exemplary records in NIH research funding, mentoring trainees, and planning urology research education.
This workshop consists of three parts: 1) two months of remote mentorship during which faculty mentors
provide feedback on specific aims and grant applications, 2) a Pre-Workshop webinar for funding mechanism
speakers to present applicable grants from their respective institutions, and 3) a 1.5-day in-person workshop.
The workshop includes presentations on key facets of grant writing and professional development including:
Crafting strong Specific Aims; composing successful research proposals; effective NIH biosketches; common
grant writing pitfalls; transitioning from K to R grants; starting an independently funded lab as junior faculty; lab
management, project management, and budgeting; creating strong mentor relationships; and social networks.
Mentors are matched to participants based on scientific area to customize feedback on methodologies. By
requiring faculty mentors and participants to meet over the course of two to three months, the participants can
improve their specific aims and grant applications under the tutelage of experienced researchers. The highlight
of the workshop is the Mock Peer Review Study Section where faculty mentors participate in a NIH-style Study
Section to demonstrate how grants are reviewed and how to avoid common errors.
The Advanced Grant Development track provides support to investigators submitting K- or R-type grant
applications within nine months after the workshop and is the target for evaluating the impact of the ECIW.
According to a recent outcomes analysis, those who participated in this track between 2015 and 2021 have
gone on to earn over $10 million in major grant funding from the NIH, DoD, and other organizations.

Public health relevance
2024 AUA Early-Career Investigators Workshop Project Narrative/Public Health Relevance Statement This application seeks support to enable the American Urological Association (AUA) to invite early-career investigators and late-stage trainees to participate in a proven, impactful workshop (AUA Early-Career Investigators Workshop, November 8-9, 2024) that provides an intensive grant writing curriculum, in-depth evaluation of grant applications in preparation for submission, instruction from senior scientific advisors in one- on-one and small group settings, and instruction in other essential elements of a successful research career. This workshop is part of a major effort by the AUA to develop an enduring urology-wide program devoted to improving the number and quality of urology research grant applications submitted to the NIH, which has been identified as a critical deficiency in the pipeline of surgeon-scientists and other urology investigators including MDs and PhDs. Without intervention by the AUA, the development of improvements in urology patient diagnosis, treatment, and hopefully cures, will be further stalled and/or eliminated, at a time when the number of patients with urologic diseases and conditions is rapidly growing.